Linking Disease Mechanisms and Outcomes in Rheumatic Diseases

PROJECT SUMMARY/ABSTRACT
Mentorship has been identified as a critical facilitator for development of clinical research faculty. This K24
renewal application seeks to provide protected time for the applicant to continue to mentor numerous trainees in
patient-oriented research (POR) and to expand the work they have started in pain and patient-centered research.
30% of the applicant's effort will be protected by this award for these activities. The applicant has demonstrated
significant aptitude in mentoring trainees at all career stages and will continue to benefit from the rich and robust
institutional environment that provides stellar research infrastructure and a large pool of patients and mentees
to work with.
During the funding period, further development of the applicant will include 1) Advanced mentorship training for
POR; 2) Training in novel technologies to bring to POR; and, 3) Expansion of our collaborative niche for
patient-oriented research in pain in rheumatic disease. These skillsets will be achieved through a combination
of seminars, meetings, courses, and collaboration with the University of Michigan (U-M) Chronic Pain and
Fatigue Research Center and the U-M Fibromyalgia Center of Research Translation (CORT). In addition, these
skillsets will integrate and grow through continued mentorship of trainees within currently funded POR and new
approaches through the K24 mechanism. These research opportunities include: work that examines the role of
type I interferons on photosensitivity and pre-disposition to inflammation in lupus skin (Project 1); Heterogeneity
of interferon sources and their impact on disease phenotype (Project 2); A large, novel immunophenotyped
cohort of lupus and psoriasis/psoriatic arthritis patients that provides large scale datasets for analysis and clinical
correlation (Project 3); and paired patient-reported outcome, pain surveys, social determinant of health and
activity monitor datasets paired with biologic and clinical data from project 3 (Project 4). Successful completion
of this award will result in successful mentoring of current and future mentees in POR and further expand the
POR program of the applicant to ensure continued mentoring opportunities and development of the next
generation of physician scientists in rheumatic disease research.

Public health relevance
PROJECT NARRATIVE The goals of this K24 application are to support Dr. Kahlenberg's continued development as a mentor and to sustain and expand a successful research training program for Patient-Oriented Research (POR) through an interdisciplinary translational research program which focuses on disease mechanisms and outcomes in rheumatic diseases. The awarding of the K24 Mid-Career Investigator Award would ensure that the candidate continues to have significant time for mentoring current and future mentees and securing funding to support her research program. Discoveries supported by and mentees supported through this research are directly relevant to the NIH's mission to foster fundamental discoveries and their applications to protect and improve public health.